Early brain development in children born to depressed mothers in high and low income settings

Expectant mothers are 2-3 times more likely to experience depression in low-resource environments and their
children are at enduring risk of developing mental health problems, however it is unknown whether, when and
how early brain development contributes to this risk. Here, two early-career investigators from South Africa
propose to combine data from six large cohorts with repeated child brain imaging assessments between O and
6 years of age, to carefully map trajectories of brain regional growth and brain network integration in children
born to depressed mothers in high-income settings and in South Africa. This project will provide important
insights into critical periods in brain development for early manifestations of mental health problems in exposed
children, and this can help to guide preventative strategies in both high-income and low-income settings.

Public health relevance
PROJECT SUMMARY Antenatal maternal depression (AMD) is a global mental health problem that is experienced by children in low- and middle-income countries (LMIC) 2-3 times as frequently as in high-income countries and puts them at risk of mental health problems even after maternal depression resolves. There is evidence to suggest that atypical neurodevelopment of the amygdala, as well as its modulatory brain circuits, can be detected soon after birth in children exposed to AMD. However, there is a critical need for refined characterization of neurodevelopmental trajectories from birth to early childhood that can potentially mediate poor mental health outcomes after AMD exposure, especially in low-resource settings. Here, two early-career investigators from South Africa aim to delineate deviations in growth trajectories and functional and morphological integration across the amygdala, insular and prefrontal cortex following AMD exposure. A further key aim is to determine whether environmental adversities aggravate AMD-related neurodevelopmental deviations in a LMIC setting. We propose to include 6 longitudinal neuroimaging datasets that are actively contributing to ENIGMA-ORIGINs for a cross-national analysis of amygdala, insula, and prefrontal neurodevelopment related to AMD exposure in children 0-6 years of age. AMD exposure will be defined by clinically relevant thresholds in each sample. Standardized protocols for harmonized image processing are to be applied to T2-weighted, T1-weighted, and resting state brain scans. Non-linear longitudinal growth trajectories will be estimated for regions of interest, and their intercepts and asymptotes will be compared between AMD-exposed and unexposed children. The two groups will also be contrasted on indices of intrinsic network connectivity and coordinated structural expansion across regions. The aggregation of data across four continents will give the power necessary for analyses stratified by sex and child age, mediation analysis on child internalizing and externalizing psychopathology, and exploration of interactions between AMD and socio-economic status in linear mixed models. Finally, we will utilize a unique LMIC birth cohort with AMD assessment and repeated child brain imaging to examine prevalent environmental adversities such as food insecurity, intimate partner violence, and single/unplanned parenthood as moderators of AMD-related changes to neurodevelopment. This project will provide important insights into critical periods in neurodevelopment for early manifestations of psychopathology after exposure to AMD in the global as well as LMIC context. It will provide a first explorative answer as to whether and how socio-economic advantage can provide a protective buffer against deviations in early brain development following AMD exposure. South African research capacity will grow through mastery of advanced neuroimaging techniques that can eventually be applied to many different types of local environmental adversities and allow us to participate in ENIGMA as equitable, valuable partners. Finally, the project is designed to establish the principal investigators as the world leaders on the impact of maternal depression on early brain development in low-resource settings.